Molecular Basis for Transmembrane Conduction & Signaling

PROJECT SUMMARY/ABSTRACT
This proposal seeks to determine fundamental mechanisms of action of integral membrane proteins at the
level of atomic structure, and energy coupling. This knowledge involves defining structural transitions
between multiple states that drive and regulate cyclical processes. This knowledge can be useful in
targeting control over these elements in health and disease. How dynamic changes in structure are
harnessed for energy coupling of directional transport, and inhibition or modulation of function are goals.
How voltage sensing domains activate voltage-gated ion channels is a current theme. We and others define
changes in voltage sensing domains that accompany resting to activated state transitions in terms of atomic
structures. We hope to see if it is possible to determine changes using methods of triggering voltage change
across the membrane in liposomes. We wish to define how these changes in voltage sensing domains are
so effectively coupled to gate the central ion channel when often the 'active state' reveals an apparently
closed pore, a seeming contradiction. Our hypothesis is that it is the loosening of structural elements in the
channel rather than a gate opening that alters probability of opening. Hence the structural changes will be
accompanied by computational simulations that help understand the dynamics that control gating. Our
current approach uses carefully selected, mostly intracellular voltage-gated ion channels since they often
can be tuned to obtain both electrophysiologically defined resting and activated states at zero voltage.
These include two-pore channels from endolysosomes, and a hyperpolarization activated channel, AKT1
from plant vacuoles. A second theme concerns the fundamental mechanisms by which secondary
transmembrane transporters, crucial to cell viability, couple an energy source such as an ion gradient, or
electrostatic potential, to control import or export of specific biomolecules, and export of drugs. By
measuring transport, specificity, and determination of atomic structures in multiple states throughout their
cycle we seek to define mechanisms using mutational analysis, and computational simulation. The portfolio
includes an essential transporter, and therefore a drug target, from Mycobacterium tuberculosis, of yet
unknown function, a uric acid transporter important in human disease, and transporters of phosphate and
sulfate as paradigms of organic anion import in eukaryotes. These transporters provide a roadmap to
targeting these processes with inhibitors and activators, that is of therapeutic advantage in infectious
diseases like tuberculosis, diseases of mis regulation, and cancers. In proposing a MIRA I seek to enhance
the scope of our NIGMS funded research to include fundamental studies of ATP-driven ABC transporters.
The number of target transporters and channels at any one time is chosen to balance the barriers in some
research targets, against more rapid progress in more mature projects.

Public health relevance
PROJECT NARRATIVE The proposal seeks to determine fundamental mechanisms of action of integral membrane proteins and seeks to define, modes of regulation, substrates and the basis for specificity, and inhibition at the level of atomic structure. Areas of current focus are on how voltage changes activate voltage gated ion conducting channels, and fundamental mechanisms of secondary transporters defining normal substrates, energy coupling, and inhibition. The proposal also seeks to expand the scope of NIGMS funded research to include mechanisms of ATP driven transporters of importance in human and pathogen biology.